Identifying palliative care needs among nursing home residents with and without Alzheimer's Disease and related dementias

SUMMARY/ABSTRACT
Nursing homes play a crucial role in caring for individuals facing serious illness, including many individuals
living with Alzheimer's Disease and related dementias and multimorbidity. Nursing home residents commonly
experience burdensome symptoms, reduced quality of life, unpredictable disease trajectory and low-quality
end-of-life care. Despite the widely recognized need to enhance palliative care for this vulnerable population,
nursing home residents, including those with Alzheimer's Disease and cognitive impairment rarely receive such
care. This is partly due to difficulties identifying residents with unmet palliative care needs. The primary
objective of the proposed study is to address the national priority of improving palliative care for nursing home
residents by developing an efficient, innovative, and resident-centered method to identify those with unmet
palliative care needs, communicate these needs to providers, and stratify residents to the appropriate level of
palliative care (primary palliative care, specialty palliative care) with focus on enhancing applicability for
residents with Alzheimer's Disease and related dementias. Specifically, the candidate seeks to (1) evaluate the
content and face validity and iteratively refine a palliative care screening tool; (2) develop contextual
understanding, implementation strategies, and training materials for the effective deployment of a palliative
care screening tool, customized to the specific needs of the nursing home setting; and (3) pilot test the
screening tool and training in real-world clinical settings and evaluate the psychometric properties of the
palliative care screening tool. To achieve these aims, the project will involve a Delphi study with an expert
panel and cognitive interviews with nursing home staff. Co-design workshops will be used to develop
contextually relevant and effective training materials and implementation strategies for deploying the screening
tool in nursing homes, ultimately enhancing successful integration and impact. The pilot study will enlist
nursing home staff to implement the tool, scoring the tool quarterly alongside routinely collected assessment
data. The specific training objectives that will provide the knowledge and skills to complete the research aims
are to gain expertise in: (1) community-engaged research (including Delphi methods), (2) implementation
context and strategies, and (3) conducting research with patients who have dementia and nursing home
clinical trials. The research environment at the University of Colorado features a number of high-quality, well-
established resources that will facilitate Dr. Cole's development. This proposal will provide the foundation for
future clinical trials that test the efficacy, effectiveness and implementation of palliative care screening
interventions to enhance care and outcomes for older adults with serious illness, such as Alzheimer's Disease
and Related Dementias, living in nursing homes.

Public health relevance
PROJECT NARRATIVE This research addresses the critical need to improve palliative care for nursing home residents, particularly individuals living with Alzheimer's Disease and related dementias. By developing an efficient method to identify unmet palliative care needs, communicate these needs to providers, and stratify residents to appropriate levels of care, the study aims to enhance the quality of life and end-of-life care for this vulnerable population. This work contributes to the broader public health goal of optimizing healthcare delivery for older adults facing serious illness.